Implementing Shared Decision-Making for Cancer Screening in Primary Care

Even more than other screening services, it is difficult to know which patients are most likely to benefit
from lung cancer screening (LCS). More difficult yet is explaining to patients the trade-offs of screening for
them personally, particularly when time for discussing preventive services is limited to less than 5 minutes
during a busy visit. Decision support can help, but must contain 3 key features to be maximally effective and
sustainable: 1) communication of accurate estimates of the benefit of LCS for an individual patient; 2) design
and content that incorporates the values and concerns of informed stakeholders (clinicians, VA leaders, and
Veterans) and a practical approach to routinely personalizing screening during busy clinic visits; and 3) design
that optimizes the tool’s fit with VA clinical workflows. In collaboration with my mentors and steering committee,
I propose to carry out work that will leverage and substantially build on a project I am co-leading – Ann Arbor
VA’s funded PROVE QUERI – which studies expeditious implementation of a more traditional shared decision-
making (SDM) tool equipped with only the first feature (individualized estimates of LCS benefit). To achieve
these goals the CDA has 3 aims.
Aim 1 – Assess informed stakeholder views (3 projects): In this aim I will use democratic deliberation
to extensively inform and engage key LCS stakeholders to understand their opinions/recommendations about
offering and discussing LCS. In project 1a (“Clinical Forum”) I will recruit a group of 12-15 clinical stakeholders
(PCPs, screening coordinators, and clinical leaders) from VA nationwide to inform them of the heterogeneity of
LCS benefit and engage them in deliberation, obtaining their recommendations for “simple boundary rules” for
when screening should be encouraged, discouraged, or left wholly to l patient choice. In project 1b (2 “Veteran
Forums”) I will recruit a random sample of up to 64 VISN 10 Veterans who are LCS-eligible and conduct 2
separate daylong forums. The core objective will be to utilize 2 content experts with differing viewpoints to
inform Veterans about the challenges of LCS implementation and the constraints of clinical practice, and then
to obtain individual and group recommendations for “simple how-to rules” clinicians can use to involve patients
in LCS discussions given the competing demands PCPs face. In project 1c I will use risk communication theory
to develop innovative new tool features that incorporate the VA Stakeholder guidance and can help guide
clinicians in how to efficiently personalize LCS.
Aim 2 – Optimize decision support ‘fit’ with the VA clinical context (2 projects): In project 2a I will
conduct a synthesis analysis of multiple streams of PROVE QUERI data to understand how LCS decision
support can be redesigned to overcome implementation challenges and enhance motivators for tool use. Then,
in project 2b I explore wiki surveys as a new method of engaging clinical stakeholders to: 1) evaluate the new
decision support content and design strategies generated in projects 1c/2a; 2) contribute new ideas; and 3)
help prioritize which strategies and content for inclusion in the upgraded tool.
Aim 3 – Pilot (3 projects): Informed by Aims 1 and 2, I will develop a paper-based prototype in project 3a.
Then, in project 3b I will assess usability by conducting 5-8 monitored mock clinical encounters (each mock
encounter will include a patient, a PCP, and a PACT staff member). In project 3c, I will pilot the tool with 30
PCPs who are purposively sampled from 6 diverse outpatient VA settings. Each PCP will first receive a 1-on-1
educational intervention. I will then test the feasibility of using my paper-based decision support with 2-3 LCS-
eligible Veterans per participating PCP. Encounters will be audio recorded to assess the content and length of
LCS discussions. PCPs and patients will complete surveys and interviews to assess satisfaction and comfort
with the LCS decision-making process. The core goal is to assess whether the tool can support brief and high-
quality personalized LCS discussions while being acceptable to a diverse sample of PCPs and Veterans.

Public health relevance
To reliably deliver effective, Veteran-centered Lung Cancer Screening (LCS), PCPs and screening coordinators need to be accurately informed about the consequences of screening for each individual patient. Because PCPs will often have less than 5 minutes to discuss LCS during busy encounters, they also need practical approaches for quickly personalizing LCS (i.e., simple rules of thumb that can be flexibly applied). In the proposed research, I will study how to deliver a personalized approach to LCS that ensures clinical decisions are Veteran-centered, more likely to help than harm, and easy to carry out in busy primary care settings. This research can help PCPs address national guidelines to discuss LCS with eligible patients, while providing a model for how decisions for similar interventions (with important pros and cons) can be personalized within the primary care setting. The studies and educational plan will help me become a national leader in personalizing primary care services and improving patient engagement in the primary care context.